Processing Of Viral Proteins For T Cell Recognition

Class I molecules of the major histocompatibility complex (MHC) bind antigens and present them to T cells bearing CD8 molecules. CD8 positive T-cells play a critical role in eradicating intracellular pathogens (particularly viruses) and tumors. They can also contribute to immunopathology, being involved in organ rejection and autoimmune diseases. There has been tremendous interest in the mechanism in understanding the physical nature of the antigen-class I complex, and in how antigens are generated and become associated with class I molecules in cells. Peptides, commonly of 8 to 15 residues produced from a cytosolic pool of proteins by proteasomes and cytosolic proteases are translocated into the endoplasmic reticulum (ER) by a MHC encoded transporter complex known as TAP. Once in the ER, peptides (sometimes after further trimming) bind to class I molecules and are transported to the cell surface. This project aims to understand how peptides are proteolytically generated, delivered and assembled with MHC class I molecules as well as the cell biology of trafficking to the cell surface. It further examines the implications of antigen processing and presentation for anti-viral CD8+ T cell recognition and the affects of inhibitory viral proteins on the processing pathway. In 2015, we have continued to be interested in the trafficking of peptide specific clusters of MHC class I molecules to the cell surface and the processing and cellular trafficking mechanisms that generate the clusters since not all cellular glycoproteins cluster.